Structure and function of the LetA lipid transport family across bacteria and eukaryotes

PROJECT SUMMARY
This application details career development and research plans that have been uniquely tailored to facilitate the
transition of the principal investigator, Dr. Cristina Santarossa, to an independent academic position. This
MOSAIC K99/R00 proposal seeks to finalize her training in microbiology, master a new technique (lipidomics),
pursue activities that will promote diversity in the biomedical sciences, and gain skills for her independent career.
The K99 phase of this award (first two years) involves a strategic career development plan that will allow
Cristina to: gain essential training in microbiology and lipidomics; participate in outreach activities to promote
recruitment and retention of students from underrepresented backgrounds; and acquire important career skills
such as lab management, mentoring, grant writing, and science communication. The plan also includes clear
and actionable steps for identifying and successfully obtaining an independent tenure-track faculty position by
the end of the K99 phase. Cristina has assembled a top-tier team of multi-disciplinary mentors and collaborators
that will oversee and guide her training, research program, and transition to independence.
The research plan proposed spans both the mentored (K99) and independent (R00) phases of the award.
It involves understanding the structure and function of the LetA lipid transport family, which is conserved across
Gram-negative bacteria and certain eukaryotes. The K99 research program aims to characterize the cellular
function of E. coli LetA. The R00 research program then aims to determine the structure and function of LetA
proteins that structurally diverged from E. coli LetA. Core research questions include: How can these structural
variants facilitate lipid transport? What substrates may they be transporting? What is their cellular role?
To address these questions, Cristina has developed a comprehensive research plan combining bacterial
genetics, structural biology, biophysics, biochemistry, and cell biology. It involves biophysical and biochemical
characterization of an E. coli protein that is in the same cellular pathway as LetA; identifying the cellular
substrates of E. coli LetA and two structural variants from K. pneumoniae and P. falciparum; structural
determination of the LetA structural variants and cellular assays to probe their function. This research will provide
key insights into the physiological role of a new mechanism of lipid transport that is likely conserved.
The proposed studies will largely take place at Johns Hopkins University, which is home to a vibrant and
collegial community of microbiologists, cell biologists, and biophysicists. This environment is ideal to facilitate
the successful completion of Cristina’s K99 research program and Cristina’s goal of transitioning to a successful
career in independent academic research.

Public health relevance
PROJECT NARRATIVE The LetA family of lipid transporters are conserved across Gram-negative and certain eukaryotes, such as Plasmodium falciparum. However, the cellular role of this protein family remains unclear. This research proposal aims to elucidate the structure and function of LetA proteins from various species, providing valuable insights into the cellular role of a conserved mechanism of lipid transport.